Modeling a national Graduated-BAC per se policy for 21-24 y/o drivers to reduce alcohol impaired driving injury and fatal crashes

PROJECT SUMMARY
The national comprehensive societal cost from alcohol-impaired crashes is estimated at over $348 billion, with
$296 billion attributable to ≥ .08 BAC cashes. In the last 10 years, the national alcohol impaired driving crash
fatality rate has increased by 24%. Young drivers are the most vulnerable group and at highest risk of being
seriously injured and/or killed in an alcohol impaired driving crash. Much of this vulnerability exists in the context
of young drivers navigating life at a time when individual freedom and mobility via driving is high as is exposure
and ease of access to alcohol and drugs. Prior to turning age 21, the Minimum Legal Drinking Age and Zero-
Tolerance laws (making it unlawful for those <21y/o who drive to have a BAC ≥.02) are in effect for youth and
young drivers with the intent of reducing harm and death due to negative consequences of alcohol use. However,
when a young driver who drinks turns 21y/o, they are no longer subject to key effective alcohol prevention/public
safety policies. Instead, when getting behind the wheel, they are subject to a BAC per se policy with a threshold
of ≥.08 g/dl. Unfortunately, this is a higher BAC limit with a well-established greater risk of serious injury and fatal
crash (i.e., BAC per se of ≥.02 before age 21 vs. a BAC per se of ≥ .08 upon turning age 21y/o).
Given the current state of an increasing national alcohol crash fatality rate and high vulnerability of young adult
drivers, there is a critical need and salient opportunity to innovate policy focused in the young-impaired driver
domain. An early reduced risk exposure approach at the time young drivers turns 21y/o and can legally drink
could yield measurable harm and fatality reduction effects. Except for the state of Utah, where the BAC per se
policy is ≥.05, all US states are at a BAC per se of ≥.08. International studies prove reductions in BAC limits to
.05 significantly reduce alcohol-impaired traffic injuries and deaths. Using epidemiologic, qualitative, and system
dynamics research methods, this study will provide a robust examination and modeling of a conceptual national
age-based Graduated-BAC per se policy (Grad-BAC) so that at the moment a young driver turns 21y/o through
age 24y/o, the BAC per se would be ≥.05. Thereafter, at age 25y/o, the BAC per se would be ≥.08 (except for
Utah, already at a BAC per se of ≥.05). This study will first examine longitudinal pre/post-age 21y/o driving after
drinking behavior as well as state-/national-level crash fatalities specifically among drivers 21-24y/o by BAC
levels. Further, changes in fatal crash rates among drivers 21-24y/o pre- vs. post-BAC per se policy of ≥.05 in
Utah and in neighboring states will be evaluated. Next, national public survey and focus groups of state policy
leaders will be conducted to assess support for or against the Grad-BAC per se policy vs. a national BAC per se
of ≥.05 for all drivers ≥21y/o. Finally, the construction of a novel and comprehensive simulation system dynamics
model will facilitate the examination of potential effects of the Grad-BAC policy among 21-24y/o that drive after
drinking. This study will effectively leverage historical and recent landmark findings in impaired driving research
and policy. Findings will prove to be highly innovative and pivotal in informing new policy and prevention efforts.

Public health relevance
PROJECT NARRATIVE In the last decade, the national alcohol impaired driving crash fatality rate has increased by 24% and the most recent data shows no evidence of a significant decline in the immediate future. Among driver age groups in alcohol impaired driving crashes, the 21-24y/o group is one of the most vulnerable and has the highest proportion of alcohol impaired drivers involved in fatal crashes. Applying a policy innovation approach with the concept of an age-based reduce early risk exposure among young drivers that drink (i.e., reducing the BAC per se limit to ≥.05 from the current ≥.08 for drivers 21 through 24y/o) could yield significant reductions in alcohol crash injury, disability, and death among drivers, their passengers, and while strengthening the public’s safety.